Brain networks in mouse models of aging

There is a rapid growth in the number of people living with Alzheimer’s disease, and only 25% get diagnosed;
still we do not know its etiology or have effective treatments. To examine factors which contribute to switching
from normal to pathological aging we focus on the APOE polymorphic alleles. The causes for increased risk, or
conversely resilience, conferred by the major APOE alleles are not known. The APOE4/4 genotype is the main
genetic risk for late onset Alzheimer’s disease (AD), and is associated with a 30-55% risk of developing mild
cognitive impairment or AD by age 85, compared to 10-15% for the APOE3/3 genotype. In contrast APOE2 is
under-represented in AD patients, and it has been associated with longevity. To help understand the
mechanisms through which APOE genes and their products differentially modulate the brain and its circuits to
switch from healthy to pathological aging, we will take an integrative and unbiased multi-disciplinary approach
using homozygous targeted replacement APOE2, APOE3, and APOE4 mice expressing the major human APOE
isoforms, under the control of the mouse endogenous ApoE promoter. APOE2 mice have a significantly longer
lifespan than APOE3 mice, which in turn have a significantly longer lifespan than APOE4 mice. These mice
reasonably match the human APOE-genotype/lifespan data. To model the human immune response to aging
we will use double-transgenic mice that express human NOS2 gene products. This modification enables nitric
oxide (NO) production and immune activity regulated by NO to better mimic the human response. Our models
include male and female APOE2/HN (APOE2/2 + human NOS2 on a mouse Nos2-/- background), APOE3/HN,
and APOE4/HN mice, at 2 ages corresponding to middle and old human age. Mice will be characterized with a
cognitive behavioral battery, and with MRI to determine selective vulnerability of brain networks. Our imaging
measures will be based on volume, vascular perfusion, and diffusion tensor imaging; and will provide
connectomes and network measures. RNA-Seq transcriptomics will identify differential expression of gene
products associated with APOE genotypes, during aging. We will use an unbiased statistical approach to map
molecular pathways underlying the behavioral and imaging phenotypes for aging. Our efforts will help build
models that explain the influence of APOE genotypes on age and AD associated network vulnerability. We
expect to hone in on pathways involved in aging, AD, inflammation, and oxidative phosphorylation. To test
models, we will add a stressor conferring risk in aging and AD, through a high fat/high sugar diet (mimicking the
Western diet). We will assess behavioral, and MRI phenotypes, in conjunction with transcriptomics, and
determine through pathway analysis how diet shifts the predicted outcomes in male and female APOE2/HN,
APOE3/HN and APOE4/HN mice. Our research will reveal mechanisms through which APOE interacts with
environmental stressors to confer vulnerability, or resilience to select brain circuits during aging.

Public health relevance
To understand potential mechanisms of APOE-mediated selective circuit vulnerability in aging and AD, we will develop an unbiased approach combining behavior, brain imaging, and transcriptomics to build predictive models. We will test these multivariate models through an interaction with environmental risk factors, exemplified by a high fat/high sugar diet. Successful modeling will enhance our ability to design mechanistic approaches addressing select brain circuits’ vulnerability or resilience to aging and age-related degenerative diseases.